Molecular Mechanisms of Complex Mixture Toxicity

DESCRIPTION (provided by applicant): Environmental exposures to toxic or carcinogenic compounds rarely result from the action of single toxicants. More often, the toxic agent is a complex mixture of chemical entities in numbers ranging from a few, such as in many occupational exposures, to several thousand, as in cigarette smoke. Frequently, these mixtures include a combination of carcinogenic metals and polycyclic aromatic hydrocarbons (PAH). Of these, hexavalent chromium, a carcinogenic metal often found as an environmental co-contaminant with PAHs, and benzo[a]pyrene (BaP), a prototypical PAH, are among the top 20 hazardous substances in the ATSDR/EPA priority list. The long-range goal of the research funded by this grant has been to develop an understanding of the mechanisms responsible for the adverse health effects of exposure to binary mixtures of BaP and chromium(VI). We have shown that high-dose acute chromium treatment interferes with the assembly of productive transcriptional complexes by cross-linking HDAC1.DNMT1 complexes to promoter chromatin and inhibiting phosphorylation, acetylation and methylation epigenetic marks established by BaP-induced gene transactivation in histones H3 and H4. These changes inhibit recruitment of RNA polymerase II to the Cyp1a1 promoter, block BaP-inducible gene expression and stimulate the formation of BPDE-DNA adducts. Similarly, sustained exposure to low doses of chromium leads to gradual changes in histone marks and signal transduction pathways that cumulatively affect gene expression and silencing. Specifically, environmentally relevant doses of chromium(VI) have opposite effects on the BaP-mediated induction of CYP1A1, CYP1B1 and CYP1A2 cytochrome P450 genes, repress tumor suppressor gene expression and induce expression of pro-apoptotic genes, leading us to the hypothesis that environmentally relevant binary mixtures of chromium(VI) and BaP have a synergistic effect on BaP toxicity and carcinogenicity. Based on our findings, the objectives for the next 5 years of this grant are, (1) to elucidate the epigenetic mechanisms by which low-dose, long-term exposure to chromium affects BaP-inducible gene expression; (2) to evaluate how chronic exposure to environmentally relevant chromium doses in drinking water affects BaP toxicity and carcinogenicity. Epigenetic modification of gene expression is a key element of the developmental and carcinogenic outcomes of exposure to chromium, alone or in combination with PAHs. Hypermethylation of the promoter of the tumor suppressor p16ink4a gene has been found in chromium-exposed workers who developed lung cancer, although p16ink4a promoter methylation accounts for only one third of cancer in this population, suggesting that there may be additional chromium targets and alternative mechanisms underlying cancer development. The knowledge derived from this research will have a major impact on the medical translation of these epidemiological findings and, by identifying molecular targets useful to reduce disease incidence, will significantly contribute to the development of therapeutic and preventative measures. PUBLIC HEALTH RELEVANCE: Environmental exposure to hexavalent chromium in drinking water and cigarette smoking and occupational exposure in the workplace are often compounded with concomitant exposures to aromatic hydrocarbon procarcinogens, resulting in health problems including lung, stomach and intestinal tract tumors. The objective of this grant proposal is to evaluate how mixtures of hexavalent chromium and aromatic hydrocarbons cooperate to cause greater toxicity and carcinogenicity than the sum of the toxicities and carcinogenicities of the two compounds. The knowledge derived from this research will identify molecular targets to reduce disease incidence and will significantly contribute to the development of therapeutic and preventative measures with major impact on the treatment of the diseases caused by these agents.

Public health relevance
Environmental exposure to hexavalent chromium in drinking water and cigarette smoking and occupational exposure in the workplace are often compounded with concomitant exposures to aromatic hydrocarbon procarcinogens, resulting in health problems including lung, stomach and intestinal tract tumors. The objective of this grant proposal is to evaluate how mixtures of hexavalent chromium and aromatic hydrocarbons cooperate to cause greater toxicity and carcinogenicity than the sum of the toxicities and carcinogenicities of the two compounds. The knowledge derived from this research will identify molecular targets to reduce disease incidence and will significantly contribute to the development of therapeutic and preventative measures with major impact on the treatment of the diseases caused by these agents.